CORE C: Clinical, Data Management and Statistical Modeling Core

SUMMARY (CORE C)
The Clinical, Data Management, and Statistical Modeling Core (Core C) will be instrumental for the success
of the P01 Program. In Aim 1, the Core will continue to conduct the Pediatric Dengue Cohort Study (PDCS) in
Managua, Nicaragua. This cohort study is the longest continuous cohort study of dengue and as such is an
invaluable source of samples and clinical data from children with natural sequential dengue virus (DENV)
infections. Both retrospectively and prospectively collected samples and data will be available to the P01 Projects
and Cores. Core C will oversee all aspects of running the PDCS including enrollment, sample collection and
storage, data collection and management, quality control, provision of medical care, and human subjects
documentation. In Aim 2, Core C will coordinate the compilation of clinical data and the distribution of samples
available from the P01 Program dengue cohort studies in Nicaragua and the Philippines as well as a vaccine
challenge study at the NIH. To this end, the Core will design, maintain, update and oversee the P01 Program
databases, which will include clinical data and sample characteristics and availability. Core C will provide tailored
data sets and assist in selection of analysis-specific biological specimens, ensuring efficient data sharing and
sample distribution through the implementation of high levels of quality control. This will include having a data
manager at the University of Michigan (UM) who will compile the data from the clinical sites and use it to
assemble data sets, including the creation of any necessary variables for P01 Program sites. Core C personnel
at UC Berkeley will be responsible for receiving samples from Nicaragua, maintaining an inventory, and
distributing the samples to P01 Projects in response to requests and in coordination with the data manager at
UM. Finally, sequencing and phylogenetic analysis of local dengue viruses will be performed in Nicaragua. In
Aim 3, the Core will maintain a copy of immunological data generated through the Projects 1-3 and Core D and
will deposit data into ImmPort. P01 investigators will be able to submit data for upload to and download data
from ImmPort, facilitating the flow of information across all P01 Program partners and making data publicly
available. In Aim 4, the Core will provide statistical and analytic support to all Projects and Cores, including
sample selection, study design, sample size calculation, and statistical analysis, as well as machine learning,
antigenic cartography and antibody landscapes. Core C will also integrate data collected through the P01,
including a cross-P01 evaluation of assays (previously identified by the Consortium as potential correlates) to
define the most appropriate biomarkers of protection and risk against dengue disease in the context of both
natural infections and vaccines, different geographic regions, and different study designs. Taken together, the
Clinical, Data Management and Statistical Modeling Core will play an essential role in the P01 Program by
providing data and samples to scientific Projects and Core D for the ultimate purpose of identifying both natural
and vaccine-induced immunological determinants of protection and risk against dengue disease.

Public health relevance
NARRATIVE (CORE C) This P01 addresses the critical need to improve understanding of human antibody, B cell and T cell responses to dengue virus infection and vaccination and to identify immunological determinants of protection and pathogenesis. Core C will continue the longstanding Nicaraguan Pediatric Dengue Cohort Study to provide key samples from natural repeat dengue virus infections. It will also support the efficient management and distribution of samples and data from the Nicaraguan cohort, a cohort study of dengue vaccination in the Philippines, and a vaccine challenge study at the NIH to Projects and Cores, collaborate on the selection of samples, maintain internal and external P01 databases and provide statistical support to the P01.